Carolina Center on Alzheimer's Disease and Minority Aging Research (CCADMR)

ANALYSIS CORE
PROJECT SUMMARY/ABSTRACT
In the United States (U.S.), older underrepresented and minority (URM) adults are at increased risk of
Alzheimer’s disease and related dementias (ADRD) compared with their white counterparts. There is a critical
need to understand the role that sociocultural, behavioral, and environmental determinants play in the
production and persistence of these racial disparities in ADRD. It is important to educate a racially diverse
group of scientists in the use of population-based datasets to help inform secondary analyses that can answer
such questions. The Analysis Core (AnC) aims to: (1) provide support in population-based secondary data
management, analysis, and programming to AD-RCMAR Scientists to enhance the methodological rigor of
their pilot projects and ensure their success; (2) develop additional resources to facilitate use and analysis of
the population-based datasets Carolina Center on Alzheimer’s Disease and Minority Research (CCADMR) will
support; (3) provide support in the dissemination of pilot project findings at the local, regional, and national
levels, and (4) provide continuing support to AD-RCMAR Scientists as they develop their subsequent
proposals based on pilot study findings for submission to National Institute of Aging (NIA) or similar funding
sources. The AnC will provide the data management and analysis infrastructure for the AD-RCMAR as well as
train AD-RCMAR Scientists in rigorous methodological approaches to population-based ADRD research
focused on identifying and understanding determinants of ADRD. The AnC will provide mentoring and research
education in effective data management, analysis, interpretation of theoretically informed research questions,
and translation of analyses into presentations and publications. The AnC will also support AD-RCMAR
Scientists in the use of population-based datasets, including the South Carolina Alzheimer’s Disease Registry,
the Health and Retirement Study (HRS), and the Behavioral Risk Factor Surveillance System (BRFSS). The
AnC is well-prepared to mentor AD-RCMAR Scientists. Not only are the Co-Leads nationally recognized
scholars in biostatistics and population science, the AnC provides access to the South Carolina Alzheimer’s
Disease Registry, which is the nation’s oldest and most comprehensive state-wide registry of diagnosed cases
of ADRD, which is linkable to a variety of social and health-related datasets. These strengths and innovative
characteristics of AnC will enable it to contribute to the mentoring of a cadre of URM scientists in rigorous
methodological and analytic approaches suitable for answering complex questions about the sociocultural,
behavioral, and environmental determinants of ADRD health disparities. The educational opportunities
provided by the AnC will increase the number of URM Scientists trained in the effective use of secondary
analyses to address ADRD disparities in the Southeast U.S. The education will also enhance the rigor and
impact of the work conducted on determinants of ADRD.